Screening for Substance Use with Computer Assisted Self Interview in Primary Care

PROJECT SUMMARY I am a physician and early career translational investigator, with a research focus on identifying effective approaches for integrating substance abuse treatment into general healthcare settings. Because screening patients for substance abuse is time consuming on the part of clinicians, I propose research to address the validity of patient self-administered screening. The specific research and training aims of this study are integrated around two primary areas of focus: behavioral research methods (survey research, quantitative analysis, qualitative methods) and implementation research. Each of these areas is anchored by an experienced mentor with corresponding expertise, and further developed through didactic instruction combining coursework and directed readings as well as research experience. Under the sponsorship of my primary mentor Marc Gourevitch, MD, MPH, my research and training plans utilize the clinical and academic resources of New York University-Langone Medical Center and Bellevue Hospital, where substance abuse treatment and research has been a longstanding area of emphasis. My proposed study explores an innovative approach to improving rates of substance use screening in primary care, a major impediment to which has been the lack of a brief instrument that can accurately and efficiently identify patients with unhealthy substance use behaviors. The widely accepted and validated Alcohol, Smoking and Substance Involvement Screening Test (ASSIST) is too lengthy for the typical medical visit, and greatly under-utilized as a result. I will adapt the ASSIST, which was designed and validated to be administered as an in-person interview, to an audio guided computer-assisted self interview (ACASI) that patients can complete prior to their medical visit. I plan a mixed methods study in 3 phases to 1) adapt the ASSIST for ACASI administration in an urban safety- net primary care clinic population; 2) test its validity relative to the traditional interviewer-administered ASSIST; and 3) explore physician attitudes to using these screening results to address substance use in the primary care office.

Public health relevance
PROJECT NARRATIVE The proposed study will make a valuable contribution to advancing the integration of substance use screening into regular primary care practice. This is an important step toward my long-term goal of developing, implementing, and disseminating simple but effective interventions that improve the capacity of medical systems to respond to the health burden of substance abuse and dependence. My research, mentorship and training activities lay the groundwork for a line of research that will define my career as an independent investigator and physician leader in improving the health of substance users. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS There is intense interest in identifying and addressing substance use in general healthcare settings, yet significant challenges exist to integrating this practice into regular medical care. Substance abuse leads to more death and disability than any other preventable health condition, yet only a minority (~10%) of those with drug and alcohol use disorders receive specialized treatment.8,9,10,11 Primary healthcare providers often represent the only health system contact for this population, particularly for those who have not yet developed severe drug disorders.12,13,14 A major impediment to large-scale implementation of substance use screening in primary care is the lack of a screening tool that can accurately and efficiently identify patients with unhealthy substance use behaviors. The widely accepted and validated "Alcohol, Smoking and Substance Involvement Screening Test (ASSIST)" takes approximately 5-15 minutes of face-to-face interaction with the patient to administer, far too long for the typical physician visit. It is thus rarely used outside of research and demonstration project settings. Having patients complete the ASSIST in the waiting room, using a user-friendly audio guided computer-assisted self interview (ACASI) approach, could foster adoption of the ASSIST even in time-pressured practice settings. Before this can be considered a viable option, however, the validity of adapting what was designed as an interviewer-administered screening instrument into an ACASI format must be demonstrated. The acceptability of this screening approach to patients and providers, and its impact on whether physicians then act on the information to address substance use issues, also needs to be assessed. To examine a more efficient strategy for implementing the ASSIST, I propose a mixed methods study in 3 phases. In Phase 1 (Adaptation and Pilot Phase), I will adapt the ASSIST for ACASI format and pilot test it with 40 adult participants for feasibility of administration, test-retest reliability and patient acceptability. Phase 2 (Validation Phase) will assess the validity of the ACASI ASSIST compared to the traditional interviewer- administered ASSIST in adult primary care patients, based on concurrence of scores generated using each administration method. I will administer both instruments to 400 participants, and convey results to both patient and primary care provider prior to the medical visit. Phase 3 (Provider Practices and Attitudes Phase) will a) determine whether screening results are utilized by primary care providers, employing chart reviews and exit surveys for participants screening positive for moderate to high risk drug/alcohol use; and b) explore provider attitudes and barriers surrounding integration of substance use screening and interventions in primary care practice through qualitative interviews with each of the clinic's ten primary care providers. Primary aims are to: 1. Assess the validity of the ACASI ASSIST, compared to the traditional interviewer-administered ASSIST, in an adult primary care population. Substance use scores generated by the ACASI ASSIST will be compared to those from the existing standard (interviewer-administered ASSIST) to determine whether there are significant differences in responses to the ACASI version that could constitute a threat to validity of the ACASI method of administration. 2. Determine the acceptability of ACASI substance use screening to patients in the primary care setting. Acceptability is based on rates of patient participation and completion of the ACASI ASSIST; exit surveys; and in-depth interviews with a subset of participants in Phases 1 and 2. Secondary aims are to: 3. Examine the effect of ASSIST screening results on physician decisions and intentions to address substance use issues at the point of care. Physician response to substance use screening results will be assessed for those participants with ASSIST results indicating moderate to high risk alcohol and/or illicit drug use, based on a) chart review and b) participant exit survey. 4. Assess attitudes and barriers surrounding integration of substance use screening and interventions in primary care practice. In-depth qualitative interviews with all primary care providers will address 1) attitudes toward substance use screening and the ACASI approach, and 2) knowledge and systems-level barriers to providing care to patients with substance use disorders. This study will lay important groundwork for potentially broad dissemination of substance use screening in real-world medical practice settings, by demonstrating the validity and acceptability of an approach that removes the burden of conducting screening from medical providers, while providing them with information needed to guide interventions. Future studies will explore designing and evaluating the impact of a computer- assisted decision support tool to assist providers in addressing risky substance use in primary care; development of a briefer version of the ASSIST that may be more easily integrated into busy medical settings; and the role of web-based screening and brief intervention for high-risk populations.